Molecular mechanisms of lysosome remodeling in response to cellular stress

PROJECT SUMMARY
The lysosome is a central catabolic station that breaks down and recycles materials from
multiple pathways. Lysosome dysfunction will cause lysosomal storage diseases. In addition,
Lysosome dysregulation is also widely related to many other human diseases, such as
neurodegenerative disorders, cardiovascular diseases, osteoporosis, and cancers. To function
properly, the composition of lysosome membrane must be precisely regulated in response to
environmental cues. Dysregulation in lysosome membrane composition leads to lysosome
dysfunction and the development of lysosome-related diseases. Despite extensive research into
many other aspects of lysosome biology, how lysosome adjusts its own composition in response
to environmental cues remains poorly understood. Surprisingly, we found that many lysosome
membrane proteins are degraded under starvation. This suggests that, rather than simply global
biogenesis, the lysosome membrane undergoes dramatic remodeling, challenging the long-held
view of how lysosomal composition is regulated. However, the cellular machinery and molecular
mechanisms governing these processes are still largely unknown, positioning this proposed
research at the forefront of the field. In this proposal, we will use budding yeast as a model
system to address this emerging question through two major directions:1. Characterization of
vacuole membrane protein (VMP) degradation pathways. 2. Vacuole remodeling through
transcriptional regulation. Collectively, the results of our studies will advance the field by
uncovering the new machinery and mechanisms involved in both the degradation and
production aspects of lysosomal remodeling. Furthermore, this proposed research will be a
critical first step in understanding the role of lysosomal remodeling in lysosomal function and
lysosome-related diseases. It will also lay the foundation for developing new therapeutic
treatments that target lysosomal function by controlling its composition.

Public health relevance
PROJECT NARRATIVE Lysosome dysregulation leads to lysosomal storage diseases and contributes significantly to the development of many other human diseases, such as neurodegenerative disorders, cardiovascular diseases, osteoporosis, and cancers. This proposed study will focus on understanding how lysosome composition is remodeled in response to cellular stress and will dissect the mechanisms underlying these changes. These discoveries will significantly advance our understanding of lysosome dysfunction-related diseases, and hold promise for the development of novel therapeutic strategies.